Neuron- and Circuit-Specific Mechanisms and Adaptations Regulating Motor Function in Parkinson Disease Models

ABSTRACT
Parkinson's disease (PD) is the second most common neurodegenerative disease (after Alzheimer's
disease), afflicting tens of millions worldwide. The characteristic disease symptoms arise from basal ganglia
dysfunction that occurs secondary to loss of dopamine neurons in the substantia nigra pars compacta.
Symptomatic treatment is focused either on replacing dopamine or disrupting aberrant activity through deep-
brain stimulation in the subthalamic nucleus or the primary basal ganglia output nucleus in the primate, internal
globus pallidus (GPi). This proposal is aimed at understanding the function and dysfunction of basal ganglia
circuitry in mice, at the output of the basal ganglia to motor thalamus. In Aim 1, we will develop strategies to
identify basal ganglia-recipient motor thalamus neurons in ventral anterior/ventral lateral thalamus (VA/VL),
and characterize their projection targets and cortical inputs in awake, behaving animals. In Aim 2, we will use
sophisticated in vivo strategies to record from posterior EP neurons and VA/VL neurons as animals move their
limbs during locomotion, a fixed repetitive behavior. We will perturb activity in this pathway using optogenetics
to determine the contribution of activity in these neurons to forelimb movements, and we will examine how
activity in this pathway is altered after loss of striatal dopamine. In Aim 3, we will perform similar experiments in
mice performing a lever-pulling task, a flexible forelimb movement. We will examine both cued and uncued
versions of this task to distinguish activity generated internally vs. externally. Finally, we will examine how loss
of striatal dopamine impacts EP and VA/VL activity during flexible forelimb movements. Our overarching goal is
to understand how loss of striatal dopamine in PD leads to disruptions in basal ganglia circuit function and
motor deficits, in order to develop novel therapeutic strategies for treating PD motor symptoms.

Public health relevance
PROJECT NARRATIVE Parkinson's disease (PD) results from a progressive loss of dopamine neurons in the midbrain, most of which innervate the basal ganglia. Here, we propose to study the effects of dopamine loss in mice, focusing on the function of the entopeduncular nucleus (a rodent equivalent of the internal globus pallidus, major output nucleus of the basal ganglia, and a site of deep brain stimulation in PD) and the ventral motor thalamus. Remarkably, the function of these regions remains mysterious, yet they hold great promise for understanding PD and developing new therapeutic strategies for treating PD symptoms.